Iron and Pregnancy: Regulatory Mechanisms and Adverse Outcomes

PROJECT SUMMARY/ABSTRACT
I am a post-doctoral scientist interested in the regulation of metabolic processes important to human health and
the pathophysiology of human diseases. My long-term goal is to become an expert and academic leader in the
field of iron homeostasis, answering questions and developing applications relevant to human health and
disease. I aim to expand the field of iron homeostasis to the previously neglected area of iron regulation during
pregnancy and the contribution of iron disorders to adverse pregnancy outcomes, and apply these discoveries
beyond pregnancy, to other common iron disorders. I will be supported by my primary mentor, Dr. Elizabeta
Nemeth, a leader in the field of anemia and iron metabolism, along with co-mentors who will contribute their
multidisciplinary expertise to train me in theoretical and methodological aspects of placental and fetal health and
disease. Through UCLA’s Clinical and Translational Science Institute (CTSI), I will choose from numerous career
development seminars that address such topics as grant writing, manuscript preparation, and ethical research.
I will also take graduate courses to obtain further training in immunology, developmental biology, bioinformatics
and biostatistics. I feel fortunate to have the full support of my institution, as well as the many advantages of
carrying out my research project at the University of California Los Angeles, a renowned research center.
This proposal outlines a 5-year research and career development plan that will prepare me to become an
independent scientist engaged in cutting-edge scientific research. This project aims to identify the pregnancy-
related hepcidin suppressor and elucidate the mechanisms mediating adverse interaction between iron
deficiency and inflammation during and outside of pregnancy. Although iron availability during pregnancy is
highly regulated, the regulatory mechanisms are not well understood. Using an in vitro bioassay to detect
hepcidin suppressive activity, I identified the trophoblast as the source of a potent and robust hepcidin
suppressor. Specific Aim 1a seeks to isolate and identify the trophoblast-derived hepcidin suppressor using an
orthogonal multi-step protein purification approach. Specific Aim 1b seeks to examine the mechanisms involved
in trophoblast-mediated hepcidin suppression, including the role of ALK2 ubiquitination. Iron disorders of
pregnancy and their interaction with inflammation commonly contribute to adverse maternal and fetal outcomes.
My preliminary data suggest the role of the TNFα-TNFR1 pathway in this process. For specific Aim 2a, I will
define the mechanism(s) of TNF-receptor regulation by iron deficiency and in Specific Aim 2b, determine the
contribution of TNF-receptor and inflammatory cytokines to adverse interaction between inflammation and iron
deficiency observed in our mouse models. This project has important and broad translation potential, and seeks
to answer high-impact mechanistic questions about the regulation of iron during pregnancy and iron pathologies
outside of pregnancy. While developing my full potential as a scientist, I aim to expand our knowledge of iron
disorders in pregnancy and in other disease states where iron dysregulation contributes to their pathogenesis.

Public health relevance
PROJECT NARRATIVE This research proposal will address fundamental biological questions of iron homeostasis during pregnancy. We propose to identify the hepcidin-suppressive factor of pregnancy and define the mechanisms of adverse interaction between maternal inflammation and iron deficiency. Successful completion will transform our understanding of maternal iron regulation during pregnancy and the pathological complications of inflamed pregnancies, with important diagnostic and therapeutic implications in disorders where inflammatory conditions restrict iron and contribute to anemia.